ShEEP Request for the purchase of a research- grade Cell Imaging Multi-mode Reader

PROJECT SUMMARY
VA Northern California Health Care System (VANCHCS) serves over 500,000 Veterans and is one of
the largest catchments in the country, including a large rural component. VANCHCS operates
research projects at both the Sacramento VA Medical Center (Mather) and the VA Martinez
Outpatient Clinic. We conduct research to discover knowledge, develop VA scientists and health care
leaders, and create innovations that advance health care for Veterans and the nation. Our Biomedical
Laboratory Research & Development Service conducts preclinical and clinical research to understand
life processes from the molecular, genomic, and physiological levels regarding diseases affecting
Veterans, with a major emphasis on cancer. Some key objectives of our research program are to
identify new cancer therapeutic targets and better understand the molecular mechanisms and
pathways underlying cancer progression, such as therapeutics resistance. To accomplish these
goals, we employ functional genomics, metabolomics, bioinformatics, genetics, and pharmacological
approaches to determine the physiological and pathological functions and action mechanisms of key
regulators to elucidate the mechanisms of action of the new therapeutics. To help our research
program reach these goals, which will directly benefit our Veterans, we are requesting funds for a Cell
Imaging Multi-mode Reader. This system would allow us to greatly expand the breadth of our
research capabilities at VANCHCS. For example, our research program would be able to perform
brightfield and immunofluorescence live cell imaging on both 2D and 3D cell cultures, as well as a
multitude of biochemical assays, such as cell viability and toxicity, cell migration and invasion,
apoptosis and necrosis, DNA damage, phagocytosis, phenotypic assays, and metabolomic assays, to
name a few. This single piece of equipment would strongly enhance our current Cancer Research
program and increase our ability to apply for competitive grant funding. Currently, our Cancer
Research group has several VA- and NIH-funded studies that would benefit directly from this Cell
Imaging Multi-mode Reader; 1) function and mechanism of small molecules in castration resistant
prostate cancer; 2) periclinal mechanistic and immunologic studies for a novel lymphoma treatment;
3) therapeutic targeting steroid sulfatase and /or Wnt5A for advanced prostate cancer; 4) targeting
tumor metabolism in prostate cancer; 5) develop potent and deliverable therapeutic peptides and
small molecule inhibitors as a novel therapeutic for Veteran colorectal cancer patients. Ultimately, our
goal is to identify cancer relevant therapeutic targets and develop novel therapeutics to better treat
Veterans.

Public health relevance
PROJECT NARRATIVE The goal of the proposed equipment, a Cell Imaging Multi-mode Reader, is to provide our VA Northern California Cancer Research Group with a tool that will allow for powerful imaging & microscopy and advanced multi-mode detection to better aid us in reaching our goals of identifying cancer relevant targets and developing novel therapies for our Veterans. With this proposed new tool, we would be able to perform time-lapse live cell imaging on both 2D and 3D cell cultures aiding in our identification of novel targets and therapeutics. We can also use this new tool to perform a myriad of cell imaging and multi-mode assays to determine cell viability/toxicity, cell migration and invasion, genotoxicity, metabolism, as well as study protein- protein and protein-small molecule interactions to help develop and test the usefulness of treatments for our Veteran patients.